A multi-disciplinary approach to uncover novel insights of endocervical mucus secretion for future drug discovery

PROJECT SUMMARY
The goal of our work is to uncover the cells and pathways that affect mucus changes downstream of hormonal
changes, with the long-term goal of using this information to inform the development of novel, non-hormonal
therapeutics targeting the endocervix that would inhibit (contraception) or enhance fertility. Endocervical cells
produce mucus, and changes in mucus consistency during the normal menstrual cycle influence human health
and fertility. For natural fertility to occur, mucus must change from a highly viscous form that blocks sperm
penetration to a highly fluid form that allows for sperm penetration and fertilization. Mucus also blocks entry of
pathogens in the gravid and non-gravid uterus, playing a key role in overall health of the uterus and upper
reproductive tract. Despite the known biological and clinical importance of the endocervix and mucus in fertility,
contraceptive studies in the endocervix have been methodologically limited as clinical studies of the endocervix
lack discriminating, biologically meaningful endpoints and laboratory studies are limited by availability of
cellular and animal models. Meanwhile, research in the airway and other non-reproductive organs have made
major advances in both understanding the physiology of mucus properties and development of research tools
for investigating epithelial-mucus interactions. Airway studies have revealed that mucin glycoproteins and
regulation of their hydration via epithelial ion channels underpin the biophysical and rheological properties of
secreted mucus. Our study builds on our prior work establishing that the endocervical epithelia is similar to
epithelia from other mucosal organs, including the mucin protein constituents, expression and function of ion
channels, and testability of cellular mucus changes. Applying the most recent knowledge of epithelial mucus
biology to cycle-dependent fluctuations of endocervical mucus characteristics leads us to hypothesize that
female sex hormones estradiol and progesterone regulate mucus biophysical properties, mediated by
alteration of epithelial cell populations and states, mucus protein composition, and ion channel transporter
activities in the endocervix. To do this, we will leverage a unique multi-disciplinary, multi-institutional
collaboration bringing together expertise in reproductive health and the endocervix, epithelial cell biology,
mucus and mucin biophysical properties, ion channel biology, and next-generation sequencing studies and
bioinformatics in the reproductive tract. We will combine 1) an established clinical trial model of steroid
hormone ablation and replacement to collect endocervical cells and mucus under highly controlled hormonal
conditions in humans with 2) a novel in vitro model of conditionally reprogrammed endocervical cells that
leverages an array of phenotypic endpoints of mucus changes adapted from highly successful airway drug
discovery programs. By combining clinical and in vitro studies, we expect to discover and validate novel
mechanisms responsible for regulation of mucus biophysical properties during the menstrual cycle in the cervix
and in turn provide a scientific basis for clinical implication of mucus as a tool to control fertility.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it explores how cervical mucus changes are regulated by female hormones. Mucus produced in the cervix can keep sperm out or allow sperm to pass through and fertilize the egg. This research would support the NICHD's mission of ensuring every person is born healthy and wanted.